TOLERANCE OF HIGH VS LOW DOSE ZIDOVUDINE ADMINISTERED TO CHILDREN WITH HIV

This study sets out to determine whether there are differences in the tolerance and side effects associated with two dosing schedules of ZDV when used to treat HIV infected children.